Alagille Syndrome Scientific Meeting - Measuring What Matters

PROJECT SUMMARY
The third Alagille Syndrome Scientific Meeting – Measuring What Matters will be held June 16-17, 2022 at
Cincinnati Children’s Hospital Medical Center (CCHMC) and the Graduate Hotel in Cincinnati. This will be the
second time that this event is held in connection with the International Symposium on Alagille Syndrome (ALGS),
the Alagille Syndrome Alliance’s (ALGSA’s) signature family conference. This scientific meeting will address an
unmet need in the scientific, clinical, and industry communities by focusing on the pleiotropic nature of ALGS
and the potential context dependent regulatory mechanisms influencing Notch pathway activity. Mutations in
Notch pathway components are identified in greater than 95% of the patients with ALGS. Because ALGS is a
disease of reduced Notch activity, the current targets to antagonize Notch activity will not benefit this patient
population. The long-term goal is establishment of a forum to address the most important problems and
opportunities for research and discovery to improve the outcome of patients with ALGS. The goal will be realized
by bringing together 1) clinicians that treat patients with ALGS, 2) investigators that focus on mechanistic aspects
of Notch signaling, 3) investigators that focus on mechanistic aspects of organ development and pathogenesis
of tissues and organs with defects identified in patients with ALGS, 4) industrial partners interested in the rare
disease space, and 5) patients with ALGS, families, and patient advocates. Our goal is to disseminate cutting
edge information to patients, advocates, clinicians, scientists and industry representative. The Specific Aims for
this interdisciplinary yet syndrome-focused meeting is to bring together a diverse community of 120 clinicians
and scientists engaged in the care of patients with ALGS and discovery of possible avenues to new, safer and
more effective way to manipulate Notch signaling in disease, development and regeneration related to ALGS.
The 13 invited speakers and 6 senior moderators represent world leaders with vast knowledge and cutting-edge
discoveries in their respective fields. This conference will provide education to everyone and stimulate
development of young investigators. Significantly, the environment and time set aside for formal and informal
discussion will generate a forum in which cutting edge technologies, ideas and discoveries can be freely
exchanged, stimulating new ideas and collaborations. Most importantly, this forum will provide the opportunity
for scientists, patients with ALGS and their families to interact and learn from each other.

Public health relevance
PROJECT NARRATIVE Focusing a scientific meeting on Alagille Syndrome (ALGS) has the potential of enhancing progress in the treatment of patients with ALGS. This scientific meeting will bring together 1) clinicians that treat patients with ALGS, 2) investigators that focus on mechanistic aspects of Notch signaling, 3) investigators that focus on mechanistic aspects of organ development and pathogenesis of tissues and organs with defects identified in patients with ALGS, 4) industry partners interested in the rare disease space, and 5) patients with ALGS, families, and patient advocates. Our goal is to not only disseminate cutting edge information to patients, advocates, clinicians, scientists and industry representative, but also to generate a forum in which cutting edge technologies, ideas and discoveries can be freely exchanged to stimulate new ideas.